Molecular Diagnostics for Malignant Effusion

[unreadable] DESCRIPTION (provided by applicant): Cancer mortality and morbidity are mainly related to recurrent chemoresistant diseases in which the molecular mechanisms are poorly understood. The objective of this study is to i) determine the biological roles of a new cancer recurrence-associated gene called NAC-1 (a member of the BTB/POZ gene family), in the development of drug recurrence and to ii) assess the molecular pathways of NAC-1 in contributing to cell survival and chemoresistance. The current project is based on our previous proposal (CA103937) which aimed to identify the potential diagnostic and therapeutic molecules in cancer. Among several novel cancer-associated markers we identified in the previous study, we focus on NAC-1 because the gene is preferentially expressed in recurrent chemoresistant ovarian cancer and its high level of expression in primary tumors is associated with early tumor recurrence. Previous studies have highlighted the emerging roles of BTB/POZ genes such as BCL- 6 in human cancer. In our preliminary study, we demonstrate that NAC-1 molecules homo-dimerize through the BTB/POZ domain. Induced expression of the NAC-1 mutant containing only the BTB/POZ domain disrupts NAC-1 dimerization, prevents tumor formation and promotes tumor cell apoptosis in a mouse xenograft model. Over-expression of NAC-1, on the other hand, enhances tumor growth of ovarian surface epithelial cells and NIH3T3 cells in mice. Based on these findings, we hypothesize that NAC-1 molecules contribute to tumor recurrence by enhancing tumor growth and chemoresistance through NAC-1 homodimerization. The oncogenic phenotypes of NAC-1 are mediated by its downstream genes including Gadd45GIP1 that participates in the Gadd45 pathway. To test this hypothesis, we proposed the following aims. Aim 1: Determine whether NAC-1 upregulation contributes to the development of drug resistance. Aim 2: Characterize the NAC-1 controlled downstream target genes that are essential for drug resistance and/or survival in tumor cells. Aim 3: Assess if Gadd45GIP1 mediates the functions of NAC-1 through the Gadd45 pathway. It is expected that the results from this study will elucidate the roles of NAC-1 in tumor progression and will provide the molecular foundation for future development of NAC-1 targeted therapy in recurrent cancers. [unreadable] [unreadable] [unreadable]